COLLATERAL MECHANICS--AGE AND LUNG DYSFUNCTION

We are trying to understand how something calledcollateral ventilation in the lungs changes with age. We will measure collateral ventilation in adults and then compare it with measurements in children.